Genetic and Cellular Mechanisms of Temporal Lobe Epilepsy

PROJECT SUMMARY / ABSTRACT
This NIH K08 proposal, describes a five-year career development program in epilepsy genetics research.
Through this program, Dr. Khoshkhoo will receive training in human genetics, the experimental and analytic
aspects of next generation sequencing, and single cell genomics. This new skillset will complement Dr.
Khoshkhoo’s prior research and clinical training, and ideally position him to transition to an independent
investigator position studying the functional and molecular mechanisms of genetic variants in epilepsy.
The institutional resources available through Brigham and Women’s Hospital (BWH), Boston Children’s
Hospital (BCH), and Harvard Medical School (HMS) are world class and they provide the ideal environment to
foster the career developmental of young physician-scientists. Dr. Khoshkhoo’s mentor for this proposal, Dr.
Christopher Walsh (a Professor of Neurology at HMS and HHMI Investigator at BCH), is a leader in genetics
and genomics of human neurologic diseases. Dr. Walsh has a long track record for mentoring other trainees to
successful careers in biomedical research. In addition, Dr. Khoshkhoo has assembled a group of collaborators
with complementary expertise, and an Advisory Committee with extensive experience in mentoring physician-
scientists to develop independent research programs.
The primary scientific objective of this proposal is to identify the role of pathogenic post-zygotic (somatic)
mutations (variants) in temporal lobe epilepsy (TLE), and to characterize the cell-type specific and
transcriptional mechanisms through which these variants contribute to the development of epilepsy. Dr.
Khoshkhoo provides pilot data indicating that a subset of sporadic TLE cases harbor likely pathogenic somatic
variants, which supports his central hypothesis that genetic and transcriptional dysregulation caused by
somatic variants plays a key role in TLE pathogenesis. This proposal will systemically examine surgical TLE
resections for the presence of these somatic variants and investigate their cellular and transcriptional
mechanisms.
To achieve these objectives, a combination of ultra-deep gene panel sequencing, Parallel RNA and DNA
analysis after Deep sequencing (PRDD-seq), and single nucleus RNA sequencing (snRNA-seq) will be
employed. These state of the art strategies will aim to: (1) identify pathogenic somatic variants in surgically
resected hippocampal tissue from TLE patients and post-mortem neurotypical individuals; (2) determine the
cell-type(s) of mutant cells in TLE cases with known pathogenic somatic variants; and (3) examine the
downstream gene expression changes caused by these variants in TLE. These studies will not only help
establish somatic variants as a novel mechanism for TLE pathogenesis, but also investigate their cellular and
molecular mechanisms in situ. Overall, this proposal introduces a new conceptual and experimental framework
for studying TLE and the findings may have immediate diagnostic and treatment implications.

Public health relevance
PROJECT NARRATIVE Epilepsy is a serious chronic neurologic condition that affects over 50 million people worldwide, and the most common form of focal epilepsy, temporal lobe epilepsy (TLE), is frequently resistant to medical treatment resulting in significant neurologic and psychiatric morbidity. Recent research has shown that genetic mutations that arise after conception (somatic variants) may disrupt normal cellular function in the brain and cause neuropsychiatric disease. This proposal will examine the hypothesis that somatic mutations cause TLE and it will aim to identify the cell-types and gene expression changes that contribute to the development of this disease.